Administrative Core

Administrative Core Summary/Abstract
The overall goal of the Administrative Core is to maximize integration of all projects and cores, and
collaborations among Program Investigators and Core leaders. This Core is essential for coordinating
the scientific, financial, organizational, and monitoring activities, and facilitating inter-project interactions
of this multi-project grant to maximize the success of the overall multi-project research program. The
Core will be led by Dr. Elizabeth Jaffee, who has extensive experience overseeing scientific programs
at the Sidney Kimmel Cancer Center at Johns Hopkins, as well as a number of multi-project NIH funded
programs. Dr. Jaffee recently served as the Team Leader for a multi-site, multiple principal investigator
grant through Stand Up To Cancer. Dr. Daniel Laheru will serve as co-leader of this Core. Dr. Laheru
brings many years of experience conducting clinical trials in pancreatic cancer and serves as the co-
director of the Gastrointestinal Cancer program and co-director of the Skip Viragh Pancreatic Cancer
Center for Clinical Research and Clinical Care.
The specific aims are to: 1) Provide organizational and administrative management to insure success
of all projects and cores within the program; and 2) Facilitate scientific collaborations and program
oversight through the coordination of scientific and advisory board meetings for the investigators in this
program.
Drs. Jaffee and Laheru will monitor progress of all Projects and Cores, identify challenges or hurdles,
and assist with problem solving. The Administrative Assistant to Drs. Jaffee and Laheru, will be
responsible for oversight of the distribution and usage of funding provided to the individual programs
and Cores. She will also provide monthly financial reports for all projects and cores within the program,
assist investigators with non-competitive renewal applications, and provide support for manuscript
preparation and submission.
Drs. Jaffee and Laheru will convene weekly scientific meetings for all members of the Program Project,
and monthly meetings of Project and Core Leaders to ensure adequate communication between and
integration of all Project and Core teams. There will also be quarterly meetings with the internal
advisory board to monitor and provide input on the group’s scientific progress. In addition, there will be
an annual one-day scientific retreat to include all investigators and the internal and external scientific
advisors. A closed advisory board meeting will be held at the conclusion of the retreat for the advisors
to provide objective feedback to the program investigators.

Public health relevance
Administrative Core- Narrative The Administrative Core will provide organizational and administrative management, facilitate scientific collaborations and oversight, and coordinate scientific and advisory board meetings. Drs. Jaffee and Laheru will monitor the progress of each project and core, ensure communication and collaboration of projects through regular meetings, and assist with any challenges or hurdles that may arise. The administrative assistant to Drs Jaffee and Laheru will oversee the distribution and usage of funding, financial reporting, renewal applications and manuscript preparation and submission.